Systemic Glucocorticoid Signaling Induced by Breast Cancer Cell Derived Extracellular Vesicles

PROJECT SUMMARY
Despite the wide use of glucocorticoids to manage symptoms in people with solid tumors, these steroids have
been linked to tumor progression and metastasis especially in breast cancers that are negative for estrogen
receptor. Here we will investigate how extracellular vesicles produced by breast cancer cells cause an
overproduction of glucocorticoids, the “stress hormones”, and how this affects normal cells in the body to
facilitate breast cancer metastasis. The goals of this study are: (1) to identify the mechanism by which
cancer cell-produced extracellular vesicles enhance glucocorticoid production; (2) to determine the
effect of activated glucocorticoid signaling at the whole body level; and (3) to explore the use of
clinically available pharmacological inhibitors of glucocorticoids in cancer treatment. In Aim 1, we will
determine the mechanism(s) through which extracellular vesicles from breast cancer cells lead to an
overactivation of the neural control pathway that is responsible for the production of glucocorticoids. We will
focus on pre-selected microRNAs in the extracellular vesicles for their role in regulating this central control
pathway. In Aim 2, we will determine the gene regulatory effects of glucocorticoid signaling that is induced at
the whole body level. We will focus on the functional role of those genes involved in the formation of pre-
metastatic niches especially in the lungs, and will dissect the immunomodulatory and non-immune effects of
cancer-induced glucocorticoid signaling. In Aim 3, we will evaluate the anti-tumor and anti-metastasis effects of
clinically approved adrenal steroidogenesis inhibitors and glucocorticoid receptor antagonists, either as
monotherapy or in combination with a first-line treatment for breast cancer. Next, we will compare levels of
selected markers in the blood of breast cancer patients and non-cancer controls, as well as the associations of
these blood markers with indicators of glucocorticoid signaling in tumor tissues. The proposed project will
provide a new understanding of the dynamic and reciprocal communication between cancer and host at the
whole body level. We will establish the mechanisms through which tumor-derived factors, such as extracellular
vesicles, directly influence the neuroendocrine pathway that controls glucocorticoid production, and will
develop a high-resolution map for the tissue-specific and cell type-specific target genes regulated by
glucocorticoids. Results from this project may establish clinical evidence for the investigated mechanisms and
explore if we may select breast cancer patients who will benefit from adding an anti-glucocorticoid therapy to
their anticancer treatment.

Public health relevance
PROJECT NARRATIVE Signaling triggered by the glucocorticoid stress hormones is associated with poor clinical outcome in some breast cancer. Our research objective is to determine the mechanisms by which extracellular vesicles secreted by breast cancer cells enhance the production of glucocorticoids and how this contributes to the progression of cancer disease. This understanding could help researchers develop novel biomarkers and therapeutic strategies to improve cancer treatment.